Low Density Neutrophils Link Inflammation and Coagulopathy in COVID-19

Project Summary
Coronavirus disease 2019 (COVID-19) is a potentially life threatening disease caused by the novel viral
pathogen, severe acute respiratory syndrome coronavirus 2 (SARS-CoV-2). Approximately 20% of COVID-19
patients experience severe disease, typically presenting with bilateral pneumonia, and about 5% progress to
acute respiratory distress syndrome (ARDS). ARDS results from a combination of virally induced lung injury and
the rapid influx of immune cells that release inflammatory mediators leading to a hyper-activated state known as
cytokine storm. COVID-19 ARDS is further exacerbated by a unique diffuse coagulopathy leading to thrombus
formation in the venous and arterial circulations and microthrombi in capillaries of the lungs. Predisposing factors
for this coagulopathy include increased fibrinogen, activated coagulation cascade, platelet activation, hyper-
inflammation, neutrophil extracellular trap (NET) formation, and endothelial cell damage. Understanding the
pathophysiology of COVID-19 coagulopathy and ARDS is critical to finding effective therapeutic interventions.
Accumulating evidence indicates critical roles of neutrophils in both ARDS and immunothrombosis in COVID-19.
Our preliminary studies identified a novel population of low-density neutrophils (LDN) which expresses
intermediate levels of CD16 (CD16Int LDN) in COVID-19 patients. The number of CD16Int LDN correlated with
disease severity, levels of inflammatory cytokines IL-6/TNF-a, D-dimer levels, and clinical outcomes. In addition,
CD16Int LDN showed spontaneous NET formation and evidence of in vivo platelet activation and granule
exocytosis. Based on these findings, we postulate that CD16Int LDN play a critical role in the induction of
coagulopathy and pulmonary inflammation in severe and critical COVID-19 patients. Three specific Aims
are proposed to further dissect the underlying mechanisms. Aim 1 will comprehensively characterize LDN
subsets using proteomics and transcriptomics approaches. The information gained from those studies will be
used to refine our CyTOF antibody panel. We will use this panel to track differential neutrophil clusters in
longitudinal patient samples. Aim 2 will determine LDN subsets functional changes during disease progression
and their contributions to dysregulated inflammatory response and coagulopathy in severe and critical COVID-
19 patients. Neutrophil degranulation, NET formation, phagocytosis, chemotaxis, apoptosis, and cytokine
release will be examined. We will also determine if LDN promote coagulopathy in COVID-19 patients. Aim 3 will
determine whether inhibition of neutrophil granule exocytosis using our novel TAT-fusion protein inhibitors
prevents activated neutrophil-mediated functional changes and hypercoagulation. We will also use a hACE2 Tg
mouse model to determine the in vivo efficacy of TAT-fusion proteins on lung inflammation and impaired function.
Successful completion of this proposal will provide novel insights into COVID-19 pathophysiology by defining the
role of a unique subset of neutrophils and by establishing neutrophil degranulation as a therapeutic target for
inhibiting inflammatory lung injury and immunothrombosis in COVID-19.

Public health relevance
Project Narrative Severe acute respiratory syndrome coronavirus 2 (SARS-CoV-2) causes COVID-19 and has resulted in ongoing pandemic, tragic loss of life, and dire economic consequences. COVID-19 patients with severe and critical disease also develop pulmonary inflammation and abnormal bleeding problems. We propose to study the mechanisms underlying these problems and develop a novel therapeutic approach; this will help us achieve rapid progress toward overcoming the challenges of COVID-19.